PROGRAMMING AND ANALYTICAL SUPPORT TO ENHANCE SEER DATA WITH DATA FROM THE CENTER FOR MEDICARE AND MEDICAID SERVICES CONSUMER ASSESSMENT OF HEALTHCARE PROVIDERS AND SYSTEMS SURVEY.

Programming and analytical support to enhance SEER data with data from the Center For Medicare and Medicaid Services Consumer Assessmento of Healthcare Providers and Systems Survey.